Investigating the role of active Rap1a binding IQGAP1 in choroidal neovascularization

PROJECT SUMMARY
Neovascular age-related macular degeneration (nvAMD) is a leading cause of central vision loss in individuals
over the age of 50 years. Vision loss occurs when choroidal endothelial cells (CECs) transmigrate the retinal
pigment epithelium (RPE) into the neurosensory retina and form choroidal neovascularization (CNV). Current
standard of care includes agents that inhibit the bioactivity of vascular endothelial growth factor (VEGF).
Although anti-VEGF agents have reduced CNV and improved visual acuity in patients, there are concerns
about possible adverse effects on neuronal and glial health in the retina from long-term VEGF inhibition. Thus,
better understanding of downstream VEGF signaling in CECs is necessary to identify more targeted
therapeutic approaches. One of the downstream effectors is Rac1, a Rho GTPase that in the GTP-bound state
regulates CEC transmigration. VEGF-mediated Rac1GTP is sustained by binding IQ motif containing GTPase
activating protein 1 (IQGAP1), a multidomain GTPase-binding protein, at a specific domain. Therefore,
interfering with Rac1GTP/IQGAP1 binding may be an approach to inhibit CEC migration and prevent vision-
threatening CNV. Cultured CECs that express constitutively active Rap1a, a Ras GTPase that also binds to
IQGAP1, had reduced VEGF-mediated Rac1GTP and Rac1GTP/IQGAP1 interactions. Together, these results
suggest that increased Rap1aGTP/IQGAP1 binding in CECs reduces VEGF-induced Rac1GTP, CEC
migration and CNV by interfering with Rac1GTP/IQGAP1 binding. This proposal will determine the mechanistic
role of Rap1GTP binding the IQ domain of IQGAP1 on Rac1GTP/IQGAP1 interactions in Specific Aim 1 and in
vitro angiogenesis in Specific Aim 2. In Specific Aim 3, this proposal will determine the mechanistic role of
Rap1aGTP/IQGAP1 interactions in endothelial cells during CNV development. Methods include: isolation of
CECs from adult human donor eyes; transfection of CECs with mutant IQGAP1 constructs; pharmacologic
activation of Rac1 and Rap1; co-immunoprecipitation; western blot; Matrigel migration assay; tube formation
assay; proliferation assay; Rap1b null mice and tamoxifen-inducible endothelial-IQGAP1 knockout mice;
murine laser-induced CNV model; intravitreal injections of agents that activate Rap1; flow cytometry;
immunohistochemistry of RPE/choroid flat mounts and cryo-sections; Micron IV imaging; and spectral domain
optical coherence tomography. These studies will elucidate a potential mechanism of regulating
Rac1GTP/IQGAP1 interactions, which has an important role in VEGF-induced CEC migration and CNV
pathogenesis, and potentially identify targeted therapeutic approaches that can reduce risks from current
standard of care VEGF inhibitors. Furthermore, this fellowship application outlines a detailed research and
clinical training plan to help the candidate become a successful physician-scientist in ophthalmology.

Public health relevance
PROJECT NARRATIVE Neovascular age-related macular degeneration is a leading cause of central blindness caused by pathologic blood vessel growth from the choroid into the neural retina. Current standard care involves inhibiting vascular endothelial growth factor (VEGF), which also has an important function in maintaining physiologic neural health in the retina. Therefore, this study aims to understand regulation of downstream VEGF signaling in choroidal endothelial cells to prevent aberrant angiogenesis and identify targeted therapeutic approaches to reduce risks from current standard of care VEGF inhibitors.